Evaluation of smoking-associated genes in disparate Appalachian head and neck cancer

PROJECT SUMMARY
Late-stage, HPV-negative (HPV-) head and neck squamous cell carcinoma (HNSCC) (or HNC-) is the most lethal form of
HNSCC. HNC- occurs at the highest incidence in the Appalachian region, where a large segment of this population is rural,
economically disadvantaged and medically underserved. The Appalachian population is the highest user of tobacco in the
nation, a behavior directly linked to disparities in HNC- incidence and mortality. As such, there is a pressing need to identify
the underlying genomic mechanisms responsible for the disparate survival in tobacco-positive Appalachian HNC- patients
as an essential step towards improving medical outcomes for these patients. Single gene informatic analysis of national
cohorts has identified elevated copies of multiple genes associated with smoking. The majority of these genes map to
chromosome 11q13 cytobands, the most commonly amplified region in HNC- and long known to be associated with
reduced survival. 13 smoking-correlated genes overexpressed from the 11q13 amplicon correspond with decreased
survival, increased risk of death and elevated risk of lymph node metastasis. While some genes in this region have been
well studied as drivers of HNC- progression, other genes identified by this analysis have unknown roles in cancer and may
present new targets for therapeutic intervention. The overall goal of this proposal is to identify the roles of
uncharacterized genes from the smoking-associated expression signature (SAES) in the 11q13 amplicon that contribute to
neoplastic progression of Appalachian tobacco-positive HNC-. Our central hypothesis is that overexpression of novel
11q13 genes in the SAES contribute in driving reduced Appalachian HPV-survival. Oncogenic screening of uncharacterized
SAES genes will be conducted to evaluate the individual contributions of each gene in promoting cancer hallmarks. SAES
gene function will be assessed using cultured cells from Appalachian tobacco-positive patients and mouse orthotopic
HNSCC models. Aim 1 will test the role of SAES genes in driving tumor cell growth, proliferation, invasion, and metabolic
reprogramming in tobacco-induced 11q13 amplified HNC-. Aim 2 will utilize experimental and clinically-parallel imaging
modalities to individually evaluate novel predicted drivers of lymph node metastasis. These genes will be tested for
promoting tumor cell growth, nodal spread, altered metabolism and proliferation in 11q13 amplified Appalachian HNC-
tumors. A comprehensive understanding of how each novel SAES gene contributes to enhancing this aggressive HPV-
subtype will fill a key gap in our knowledge regarding how the 11q13 amplicon contributes to the overall poor outcomes
seen in tobacco-associated HNC-. Results from this proposal will provide a foundation for future studies that will
mechanistically address novel tumor-promoting SAES genes identified from this work as drivers of disease aggressiveness,
potentially serving as new targets for therapeutic development and/or biomarkers to improve treatment of this highly
refractory disease in the Appalachian population.

Public health relevance
PROJECT NARRATIVE This research study will provide new information on the mechanisms by which tobacco-induced genetic damage leads to the earlier death of Appalachian individuals harboring oral tumors with the worst clinical outcomes. The proposal will systematically evaluate specific, novel tobacco-related genes that have not been previously studied for tumor-promoting effects in oral cancer other cancer type, offering new insight into potential druggable targets in Appalachian and other patient populations with high tobacco use and DNA-damaging risk factors.